Folding Assisted therapeutics for Achromatopsia

PROJECT SUMMARY Cyclic nucleotide gated channels (CNG) transduce light information into membrane potential changes in cone photoreceptors. Mutations in CNGA3 and CNGB3, genes encoding CNG channel subunits are the most common cause of achromatopsia (ACHM), an autosomal recessive channelopathy producing incomplete or complete loss of cone function. Patients have poor visual acuity, lack of color discrimination, photophobia and day blindness. Over 100 missense mutations in CNGA3 have been identified in patients with ACHM2, the majority being compound heterozygotes. A subset of CNGA3 mutations studied in heterologous systems showed functional rescue when cells were grown at low temperatures. These mutations likely have folding defects resulting in endoplasmic reticulum (ER)-retained subunits causing loss of channel function. We hypothesized that ER-retained mutants might be rescued with small molecule correctors to restore channel function as a new therapeutic approach for ACHM2. Small molecule correctors of the most common cystic fibrosis mutation, CFTR F508del have been identified and led to an FDA-approved treatment. Correctors identified from high-throughput screening on CFTR F508del show broad utility to improve function of other mutant proteins associated with inherited channelopathies. As a therapeutic strategy, we hypothesize that misfolded CNGA3 subunits might also respond to small molecule correctors and restore channel function. We developed a high-throughput calcium influx assay based on the calcium permeability of cone CNG channels; a permeant, cGMP analog was used to activate the calcium influx. Using this functional assay together with cellular localization utilizing YFP-tagged mutant channels, we will in Aim 1, characterize mutant CNGA3 channels to identify mutations which exhibit improved function in response to reduced temperature as an indicator of receptivity to rescue. Our cellular localization assay identifies ER-retained mutants and will be used as a secondary screen to assist in selecting misfolded mutants. In Aim 2, mutant CNGA3 channels will be screened against a collection of known correctors in the calcium influx assay to identify compounds which improve channel activity. Active compounds will be characterized in the localization assay to confirm their mechanism as fold-assist by shifting the distribution of mutant channels from the ER to increased membrane expression. Completion of these aims will result in a deeper understanding of the molecular basis of ACHM2 and has potential for identifying small molecules as the first step toward a pharmacological treatment for ACHM2.

Public health relevance
PROJECT NARRATIVE Cyclic nucleotide channels in retina cone cells play a central role in modulating daylight vision. Defective channels resulting from inherited mutations are the cause of achromatopsia, a rare eye disease producing reduced vision clarity, lack of color discrimination and bright light sensitivity. We propose to use high- throughput screening methods to discover compounds which improve mutant channel function as the first step towards developing new treatments for achromotopsia.